Cell-cell signaling and pattern formation in yeast

Project Summary / Abstract
Pattern formation, the spatial organization of cells of different types, is central to the development
and function of metazoans. Pattern formation also occurs in microbial communities such as biofilms and
colonies. For example, pattern formation is manifested by localization of different cell types to different
regions of a microbial community. Formation of these patterns requires communication between individual
cells, and so the first organisms to communicate were likely microorganisms within communities. From this
perspective, the most ancient and fundamental mechanisms of communication on earth evolved, and still
exist, in simple microorganisms. Here we propose that in the model genetic organism, Saccharomyces
cerevisiae, this communication involves secreted metabolites that serve as cell-cell signals. A variety of
evidence suggests that this type of communication is important in healthy and diseased human tissues.
Yeast colonies are ideal for investigating pattern formation and the cell-cell signals that underlie
these patterns. Two advantages of this organism are its facile genetics and the depth of knowledge we
have regarding this particular species. Yeast colonies contain a thick layer of meiotic cells at the top of the
colony supported by an underlying layer of feeder cells. Feeder cells are so named because they provide
metabolites to the upper colony layer. A sharp boundary forms between these two layers.
The focus of the proposed research is the mechanism of differential partitioning-- a change in the
relative allocation of the colony, the ratio of meiotic cells: feeder cells, in response to environment (food,
temperature, etc.). We propose that communities adapt to their environment by differential partitioning.
Our specific aims are to determine: 1) the role of signaling pathways and their target transcription
factors in regulating differential partitioning in response to environmental cues, 2) the role of secreted
metabolites as a type of cell-cell communication that controls this partitioning.
To achieve these aims, we will utilize several approaches. First, we will use flow cytometry to
distinguish different colony subpopulations, corresponding to different cell fates, and how environmental
cues and genetic mutations drive the relative allocation of these subpopulation. Second, we will determine
the temporal/spatial expression of genes within colonies using fluorescent-tagged proteins and colony
sectioning. Third, we will identify and characterize metabolites serving as cell-cell signals that control
colony organization.
The proposed research has potential connections to broader biological topics that are difficult to
study in other organisms. These include biofilm pattern formation, which contributes to the pathogenicity of
some yeast species, the effects of environment on development, and the role of secreted metabolites in
regulating multicellular functions.

Public health relevance
Project Narrative: In the short term, the project will contribute to the understanding of how yeast cells communicate and organize in communities through shared metabolites. In the longer term, this knowledge may provide a framework for how environmental factors and cell- cell signals affect human development, tumor progression, and deadly pathogenic biofilms.